Diagnostics Core

ABSTRACT- DIAGNOSTIC CORE
The Diagnostics Core provides comprehensive laboratory testing for Lyme disease in a CLIA-certified clinical
laboratory setting. Its purpose is to provide standardized laboratory services to the Clinical Core, to assist in
characterizing enrolled subjects, and to provide archived human samples to support the Projects. Laboratory
testing will include only well-established assays and procedures, rather than experimental diagnostic methods
that will be evaluated in the Projects. Services provided by the Diagnostics Core will include pre-analytical
sample processing (e.g., serum or plasma separation, isolation of peripheral blood mononuclear cells); routine
chemistry and hematology tests; serum antibody testing using a standardized suite of well-described
commercial assays selected for high performance and reproducibility; skin biopsy culture and PCR for Borrelia
performed using established protocols; and multiplexed PCR targeting a full complement of tick-borne
infectious agents. The Diagnostics Core will also manage plasma sample transport to a referral laboratory for
pathogen detection using metagenomic sequencing.

Public health relevance
NARRATIVE: Diagnostic Core Crucial to any groundbreaking study of PTLDS will be the availability of properly collected and stored human samples obtained from well-characterized patients with Lyme disease and control subjects. The Diagnostics Core will assist in comprehensive subject characterization by performing a predefined battery of laboratory diagnostic tests on each enrolled subject, the results of which will be correlated with clinical findings. We will also develop and maintain a biorepository of archived human samples from each well-characterized subject, for use by the project investigators to support research aims.